Prenatal and infant household air pollution exposure, the human microbiome and virome, and childhood lung function: the GRAPHS randomized controlled trial

Project summary
In low- and middle-income countries ~2.8 billion people are exposed daily to smoke from cooking fires, termed
household air pollution (HAP), resulting in an estimated 2.3M deaths and 91.4M disability adjusted life years in
2019. A large proportion of HAP-attributable deaths are due to respiratory disease over the life course.
Establishment of lung health in childhood is critical to reduce risk for future respiratory disease. We propose to
build on an existing pregnancy cohort in Ghana – the Ghana Randomized Air Pollution and Health Study, or
GRAPHS – to assess how randomized early life air pollution exposure programs subsequent microbiome and
virome over childhood, and how these changes are further associated with lung function and lung function
growth. We will use well-established, validated methods to assess these outcomes. In the long run, our
research will help build the evidence base for public health interventions to reduce HAP exposure-associated
respiratory disease.

Public health relevance
Project Narrative The proposed research project will improve public health by advancing our understanding of the impact of air pollution exposure during pregnancy and age one on childhood gut microbiome and virome and lung function. This will help inform cost-effective policies and public health interventions that may be applied early to promote optimal development and improve health.